Cerebellar Modulation of Innate Defensive Behaviors

Project Summary
Innate defensive behaviors promote survival by allowing animals to detect and respond to acute
threats within their environment, such as predators. Although innate, these defensive behaviors show
a remarkable amount of flexibility and are subject to robust habituation, suggesting that the circuitry
underlying defensive behaviors is subject to modulatory control. Our recent work suggests that the
cerebellum may provide one source of afferent modulatory influence within the periaqueductal gray.
We find that cerebellar afferents to the freezing-related circuitry in ventrolateral periaqueductal gray
(vlPAG) predominantly activate local dopaminergic interneurons, which subsequently alter the relative
strength of synaptically evoked inhibition and excitation onto freezing premotor neurons. More
specifically, cerebellar activation increases IPSC amplitudes and decreases EPSC amplitudes, which
is predicted to increase spike threshold and alter the input-output relationship, altering the integrative
properties of freezing premotor neurons. These synaptic changes are predicted to reduce the efficacy
with which synaptic input drives freezing, thereby providing a potential mechanism of behavioral
habituation across repeated trials. These results motivate testing the hypothesis that the cerebellum
modulates the expression of innate defensive behaviors through activation of local vlPAG dopamine
neurons. To test this hypothesis, a combination of in vivo behavioral and systems-level approaches
will be used to record and manipulate cerebellar activity during innate freezing behaviors to determine
the nature of the cerebellar signals produced, and their resulting effects on expression of freezing
behavior, respectively. To study the role of vlPAG dopamine neurons in modulating innate freezing
behaviors, I will similarly record and manipulate vlPAG dopamine neuron activity using fiber
photometry and optogenetic actuators. Finally, because selective lesions of vlPAG dopamine neurons
disrupt fear memory formation in mice (as do disruptions in cerebellar plasticity), I will test the
hypothesis that cerebellar associative plasticity contributes to fear memory formation by modulating
vlPAG dopamine activity. Together, these experiments provide a framework for understanding how
the cerebellum modulates innate freezing and more broadly how cerebellar plasticity contributes to
learned and innate defensive behaviors.

Public health relevance
Project Narrative Non-learned defensive behaviors are necessary for survival, like fleeing or freezing in the face of threat. Whether these response change in response to acute and chronic stress is not currently known. Here, we will test whether stress alters behavioral responses to threats and examine the brain signals responsible for such changes.